Cholesterol metabolism in mesenchymal colorectal cancer

PROJECT SUMMARY
The overarching goal of this proposal is to identify novel addictions in mesenchymal colorectal cancer (CRC)
that will create new vulnerabilities to be targeted therapeutically. This type of aggressive CRC shows a
microsatellite stable phenotype, characterized by a strong reactive desmoplastic stroma and immunosuppressed
microenvironment. Mesenchymal CRC is enriched in a transcriptomic CMS4 signature, affects about 30-40% of
all CRCs with the poorest prognosis, and lacks effective therapies. Our recently published and preliminary data
demonstrated that the loss of the two atypical protein kinase Cs (aPKCs; PKCλ/iota and PKCzeta, encoded by PRKCI
and PRKCZ genes) drives the mesenchymal phenotype in mouse intestinal tumors. Furthermore, interrogation
of human specimens and transcriptional datasets of CRC patients established the aPKCs as new suppressors
of mesenchymal CRC. Our data also show that PKCλ/iota is the one whose inactivation unleashes transformation
through the mesenchymal route, and new preliminary results, which constitute the foundation of this proposal,
demonstrated that aPKC inactivation in several models results in the upregulation of a cholesterol biosynthetic
signature and promotes cholesterol synthesis in vivo as evidenced by metabolic tracing experiments in mice.
Analysis of human CRC data and samples demonstrate a positive correlation between the activation of the
cholesterol biosynthetic pathway and mesenchymal CRC, associated with a negative correlation with aPKC
levels. Also, PKCλ/iota directly phosphorylates SCAP, an obligate regulator of SREBP2 processing, which is the
master regulator of cholesterol biosynthesis. Therefore, the central hypothesis of this application is that PKCλ/iota
by phosphorylating SCAP restrains the cholesterol biosynthetic pathway to repress tumorigenesis in
mesenchymal CRC. Building on our strong preliminary data, we will (Aim 1) determine the role of increased
cholesterol metabolism in mesenchymal CRC initiation and progression. To that end, we will determine the
impact of feeding a high-cholesterol diet (Aim 1.1) or blocking cholesterol metabolism in vivo (Aim 1.2) in tumor
initiation and progression of mesenchymal CRC tumors driven by PKCλ/iota deficiency; and determine the human
relevance of PKCλ/iota-regulated cholesterol metabolism in mesenchymal CRC (Aim 1.3). We will also (Aim 2)
determine the molecular mechanisms whereby PKCλ/iota regulates cholesterol biosynthesis in mesenchymal CRC
tumorigenesis. Therefore, we will (Aim 2.1) determine the impact of PKCλ/iota-mediated SCAP phosphorylation on
regulating the SCAP/SREBP2 complex at a mechanistic level; and (Aim 2.2) determine the functional
contribution of PKCλ/iota-mediated SCAP phosphorylation to CRC in vivo. The results from this proposal will allow
the identification of new targets as therapeutic points for intervention in mesenchymal CRC.

Public health relevance
PROJECT NARRATIVE The most aggressive form of CRC shows a microsatellite stable phenotype and is characterized by a strong reactive desmoplastic stroma and immunosuppressed microenvironment and can evolve from either serrated or conventional pathways. This type of intestinal cancer, from now on termed mesenchymal CRC, is enriched in a transcriptomic CMS4 signature, displays the poorest prognosis, and lacks effective treatments. Here we will establish the role and mechanism of action of a new metabolic addiction in this type of cancer by testing the hypothesis that PKCλ/iota restrains mesenchymal CRC tumorigenesis by inhibiting the cholesterol biosynthetic pathway through the regulation of SREBP2, the master regulator of cholesterol homeostasis.